Administrative Core

ABSTRACT ? CORE A (ADMINISTRATIVE CORE) The overarching goal of the Administrative Core is to provide the operational support necessary to successfully achieve the goals we have laid out for each project and program as a whole. The Administrative Core will be responsible for managing, coordinating, and monitoring overall progress, and supervising the entire range of the program's activities. Moreover, the Administrative Core will distribute results to scientific audiences and the general public and interact with other awarded research programs. We will maximize efficiency, cost- effectiveness, and productivity by centralizing resources used by each of the projects and core. Core personnel include the Core Lead and a Program Manager. The Administrative Core has the following specific aims: (1) provide operational oversight and integration of projects and cores, (2) monitor the progress of each of the research projects and their interactions and promotion of effective collaboration and communication, (3) provide fiscal administration and compliance, and (4) broadly disseminate results. The organization of the Administrative Core will have clear lines of authority and will leverage both an Executive Committee and a Scientific Advisory Committee to ensure effective use of resources, scientific guidance and evaluation, and clear decision-making processes. Overall, the Administrative Core will provide fully integrated administrative services for the management, communications, coordination, and financial administration of this U19.